Advanced Infrared Biology of Protein Structure & Dynamics

4. Project Summary/Abstract
Proton-transfer in proteins is a fundamental process underlying protein function, including
signaling/regulation, bioenergetics, and bio-catalysis. Understanding what triggers proton-transfer and how
proton-transfer drives subsequent functionally important structural transformations are of significant
importance to understand the structure-function relations of many proteins. Such research is hampered by
the paucity of widely accessible structural techniques for probing dynamic changes in proton positions
during protein function. The long-term goal of this project is to overcome this barrier by developing a time-
resolved infrared vibrational spectroscopy-based structural technology.
Protein infrared spectra encode rich structural information and are particularly sensitive to cleavage
or formation of X-H bonds during proton-transfer. Time-resolved infrared technology consists of three steps:
i) detecting time-resolved infrared signals that capture protein structural dynamics; ii) identifying which
amino acids contribute to specific infrared signals; iii) reliably translating infrared signals into proton
positions in proteins. In this project, we will focus on detecting dynamic changes in proton positions in
histidine side chains during protein function, using a bacterial blue-light photoreceptor (PYP) as a model
system. The three protonation states of histidine are His+ (two protons, on N & N), His0D (a sole proton
on N), and His0E (a sole proton on N). Aim 1 is to detect pH-induced changes in protonation of buried
His108 and solvent-exposed His3 in static PYP; Aim 2 is to detect time-resolved dynamic changes in
protonation states of His108 in the signaling state upon light activation; and Aim 3 is to detect chemically
activated time-resolved proton transfer in PYP. We will use high-precision FT-IR (Aim 1), time-resolved
rapid-scan FT-IR (Aim 2), and integrating a microfluidic rapid-mixing device with an FT-IR microscope for
collecting 16,000 FT-IR spectra at once using a focal plane array detector (Aim 3). We will assign infrared
signals using specific isotope-editing combined with site-specific mutations. Histidine protonation states
will be derived using vibrational structural marker bands that we recently developed.
The PI has extensive experience in advanced infrared technologies and is the director of Oklahoma
Center for Advanced Infrared Biology. The key collaborator is an expert in PYP, molecular biology and
isotope-editing of PYP. An NSF MRI funded state-of-the-art FT-IR system will be used for this project. Six
undergraduate students will carry out the FT-IR experiments, prepare various PYP samples, perform FT-
IR data analysis, contribute to FT-IR data interpretation, and present results at professional conferences.
Women, native American students, and other minority students will be encouraged to join the project via
University's three programs 1) Oklahoma Louis Stokes Alliance for Minority Participation, 2) the Center for
Sovereign Nations, and 3) the Freshman Research Scholar program.
The parent award focuses on developing new infrared-based technologies for protein structure and
structural dynamics. The requested equipment will bring extraordinary enhancements to time-resolved
study on protein structural dynamics (Aim 2). The requested equipment will increase the time-resolution
for protein structural dynamics from 10 milliseconds to 5.5 nanoseconds. This new experimental capability
from5.5 nanoseconds to 10 seconds (more than 9 orders of magnitude in time) will offer an unparalleled
structural tool to gain rich structural information underlying protein functions and is expected to make
significant impacts on the field of time-resolved protein structural biology and its applications to medically
important proteins.

Public health relevance
Project Narrative Many serious human diseases are caused by malfunctioning of proteins, including cancers. Understanding the structure-function relations of proteins is expected to guide and accelerate drug discovery process. The objectives of this proposal are to develop new experimental tools based on advanced Fourier transform infrared technologies to enhance such research.